Presynaptic modulation of synaptic inhibition onto hippocampal pyramidal neurons

PROJECT SUMMARY
Throughout the hippocampus, pyramidal cells integrate excitatory and inhibitory inputs from a diverse
population of interneurons. These cells provide feedforward and feedback inhibition onto CA1 pyramidal cells,
and can be recruited via glutamate spillover, a phenomenon that describes non-synaptic actions of glutamate
diffusing away from the synaptic cleft. The prevailing view, at present, is that glutamate spillover leads to
activation of presynaptic group III metabotropic (mGluRIII) glutamate receptors, which inhibit synaptic excitation
and inhibition only onto interneurons, not CA1 pyramidal cells. Against this interpretation, our preliminary data
indicates that spillover activation of mGluRIII receptors also exists at inhibitory synapses formed onto CA1
pyramidal cells, when experiments are performed under experimental conditions that mimic more closely the
ionic composition of the cerebrospinal fluid. The main goals in this application are: (i) to determine how mGluRIII
activation via glutamate spillover varies between excitatory and inhibitory inputs, and among inhibitory inputs
formed by different classes of interneurons; (ii) to identify the intracellular signaling mechanisms that couple
mGluRIII activation to neurotransmitter release; (iii) the determine the sub-cellular location of different type of
mGluRIII receptors at different types of inhibitory synapses onto CA1 pyramidal cells; (iv) to determine how
mGluRIII activation alters encoding of spatial information by hippocampal CA1 place cells in vivo. The proposed
experiments capitalize on in vitro and in vivo electrophysiology, and EM approaches. These findings will generate
new information on the operating principles of neuronal circuits involved in spatial map representation and will
contribute to the future development of effective strategies to treat disease states associated with hippocampal
neural circuit dysfunction, like epilepsy and autism spectrum disorder.

Public health relevance
PROJECT NARRATIVE Pyramidal cells in the hippocampus use rate and temporal codes to represent the position of an animal in space and encode, more generally, relational/declarative memory. The specific features of these codes depend on the ability of pyramidal cells to integrate excitatory and inhibitory inputs. Here, we ask how glutamate spillover modulates synaptic excitation and inhibition onto pyramidal cells in hippocampal area CA1 via activation of mGluRIII receptors, which we believe will advance our understanding of neurological disorders associated with hippocampal neural circuit dysfunction, such as epilepsy.